Cellular and Molecular Control of Normal and Disordered Erythropoiesis

Project Summary/Abstract
Red cell disorders affect more than 1 billion people worldwide, are a significant cause of morbidity and
mortality and lead to a substantial economic burden. These disorders can result from a decrease in survival or
in production (or both). Our research is focused on erythropoiesis and how this process goes awry in disorders
such as Diamond Blackfan anemia (SCD), sickle cell disease (SCD) and anemia of inflammation. Our work has
highlighted differences between neonatal and adult human erythropoiesis and used these findings to reveal the
mechanism of steroid resistance in DBA. In parallel, we studied the mechanism of action of immunomodulatory
drugs during erythropoiesis and how they increase fetal hemoglobin production in SCD. We recently identified
the nature of the erythroblastic island in normal erythropoiesis and under inflammatory conditions. Together,
these discoveries have allowed for a better understanding of normal and disordered erythropoiesis.
Nevertheless, critical basic and translational questions remain in DBA and SCD. The proposed research
program builds upon Dr. Blanc’s productive research track record to determine (i) why the erythropoietic defect
in DBA manifests after birth, (ii) how the erythroblastic island in the bone marrow contributes to the
pathophysiology of DBA and SCD and (iii) identifying new targets and treatments for DBA and SCD.
To answer these questions, we propose an ambitious research program divided into three projects. The
first will investigate the impact of differential regulation of ribosome biogenesis and cell cycle length in fetal versus
adult erythropoiesis. The second will address the contribution of the newly characterized erythromyeloblastic
island to the pathophysiology of DBA and SCD and the third will focus on identifying and testing new drugs for
the treatment of these two hematologic disorders.
As a whole this program should (i) offer new models to study ribosomal protein biology relevant to heart
and blood disorders, (ii) explain how the erythroid niche universally contributes to inflammation in hematologic
disorders and (iii) offer new therapies for the treatment of bone marrow failure syndromes and sickle cell disease.

Public health relevance
Project Narrative Abnormalities in red cell production and/or function can lead to life-threatening conditions. The program proposed in this application focuses on two red cell disorders, Diamond Blackfan anemia (DBA) and sickle cell disease (SCD) filling important gaps in our understanding of the molecular mechanisms leading to the etiology of DBA and the role of the bone marrow niche in both DBA and SCD. Completion of the program will lead to the development of novel therapies based on a better understanding of the pathophysiology of these disorders.